IMMUNOLOGICAL STUDIES ON THE MECHANISM OF HALOTHANE-INDUCED HEPATOTOXICITY

My previous work, performed at the Liver Unit, King's College Hospital, (KCH), London U.K., has demonstrated that sera from patients with halothane-hepatitis react with several halothane induced lived microsomal polypeptide antigens not expressed in normal liver. Antibodies to these antigens are specific to such patients and are not produced simply as a consequence of halothane exposure and/or liver damage, indicating that they may play a role in development of halothane hepatitis in vivo. We have now demonstrated that the antigenic sites recognized by the patients antibodies consist of a specific halothane metabolite hapten, the trifluoroacetyl group (TFA-), bound of endogenous liver proteins. These results constitute the first demonstration of an immune response in patients with drug toxicity directed against novel antigens produced by a defined covalently bound metabolite. Purification of the protein antigens is currently in progress, using affinity chromatography methods developed previously in this Laboratory for the purification of trifluoroacetylated proteins. The purified proteins will be used in animal model studies, and also for their detailed biochemical characterization.